New cell biology tools to study myelin development, dynamics, and disease

PROJECT SUMMARY/ABSTRACT
Myelin—the electrical insulator around neuronal axons—is essential in vertebrates for rapid nerve signaling,
and its loss in diseases like multiple sclerosis and following injury causes severe disability in patients. Myelin’s
traditional role as a passive electrical insulator has recently been reimagined as a dynamic process, in which
oligodendrocytes build and remodel myelin sheaths in response to neuronal activity, and metabolically support
the neurons they myelinate. These new discoveries open up many exciting new research questions, such as:
how do oligodendrocytes regulate their morphology to tune conduction velocity or other neuronal functions,
during development or in the adult central nervous system (CNS)? What roles do myelin dynamics play in
higher-order brain functions and in neurodegenerative diseases beyond multiple sclerosis? A fundamental gap
in current knowledge lies in understanding how oligodendrocyte cell biology is regulated in all of the contexts of
development, dynamics, and disease. Bridging this knowledge gap requires building innovative new tools to
break through the experimental limitations that have hindered our ability to study oligodendrocyte cell biology in
vivo thus far. The goal of this proposal is to create a viral (AAV) toolkit for studying oligodendrocyte cell biology
in vivo. This toolkit will allow for bright, sparse labeling and manipulation of single oligodendrocytes in the
mouse CNS, which will empower studies to determine the mechanisms controlling oligodendrocyte morphology
(Aim 1). In addition, this toolkit will allow subcellular targeting of reporters or perturbants to functionally-distinct
regions within oligodendrocytes, including myelin sheaths (Aim 2). We propose that this viral cell biology toolkit
will have a broad positive impact across the myelin and broader neuroscience fields, by: i) rapidly accelerating
the time from idea to discovery, compared to traditional mouse genetics, ii) simplifying experimental design via
“plug-and-play” modular construct architecture, iii) unlocking the ability to visualize and/or perturb single mouse
oligodendrocytes in vivo, and iv) creating new tools to study functionally distinct subcellular structures in
myelin. From this research, we will create and optimize a simple but powerful toolkit for studying myelin cell
biology in vivo in the mouse CNS. It is our hope that these tools can be rapidly adopted by the field, and open
exciting new frontiers in myelin research. We will share these tools as a free resource, thereby maximizing
their potential impact to reveal new cell biological insights into myelin development, dynamics, and disease.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to public health because myelin is lost in neurodegenerative diseases like multiple sclerosis and after injury—causing severe disability in patients—yet we lack a fundamental understanding of the cell biological mechanisms by which myelin forms, remodels, and regenerates. We propose to build an innovative suite of genetic tools for studying myelin development, dynamics, and disease, and broadly share these novel tools with the field. The proposed research is relevant to NIH’s mission to foster innovative research strategies that will allow fundamental creative discoveries as a basis for ultimately protecting and improving health.